Regulation of germinal center homeostasis by the BAF complex

Summary/Abstract
Germinal Centers (GCs) are specialized anatomical sites in the secondary lymphoid tissues where high-quality
adaptive immune responses are mounted. B cells within GCs undergo intricate transcriptional and epigenetic
transitions to ultimately generate effective humoral immune responses. During the GC B cell responses, specific
transcription factors define distinct stages of cellular differentiation, and efficient chromatin remodeling ensures
systematic transition between these transcriptional programs. Brg1/Brm-associated factor (BAF) complexes are
highly conserved nucleosomal remodelers that play pivotal roles in establishing cell-specific gene expression
programs during cellular differentiation and development. Notably, BAF subunits ARID1A, ARID1B, and
SMARCA4, are each mutated in ~10% of Diffuse Large B-Cell Lymphoma (DLBCL) originating from GCs,
underscoring the regulatory functions of BAF complex activity in maintaining GC homeostasis. However, the
specific contributions of distinct BAF complexes in GC biology remains unclear.
Our recent studies showed that the AT-rich interacting domain 1 (Arid1a) dependent canonical BAF complex
(Arid1a-cBAF), is indispensable for GC responses, and therefore, generation of high-affinity antibodies. Arid1a-
deficient B cells can initiate the GC program but fail to sustain GC responses. We identified important roles of
Arid1a-cBAF for establishing permissive chromatin landscapes during B cell differentiation, and simultaneously
suppressing inflammatory gene programs to maintain transcriptional fidelity in GCs. Moreover, inflammatory
signatures emanating from Arid1a-deficient B cells led to enhanced neutrophil and monocyte recruitment and
anti-inflammatory glucocorticoids rescued the differentiation of Arid1a-deficient GCs. These studies suggest that
Arid1a-cBAF activity restricts inflammatory signals through both cell-intrinsic and -extrinsic mechanisms to
preserve GC responses. We hypothesize that Arid1a-dependent BAF activity establishes the GC transcriptional
program and simultaneously restricts inflammatory signatures to promote efficient GC B cell responses. To
address this hypothesis in this proposal we will: i) elucidate the epigenetic control of GC B cell differentiation
by Arid1a-cBAF activity (Aim1) ii) examine the roles of inflammatory signatures associated with Arid1a loss in
disrupting GC responses (Aim2) iii) define altered immunological landscapes and dissect their contributions
to perturbation of GCs upon Arid1a loss (Aim3). In summary, the proposed studies will provide comprehensive
mechanistic insights for the role of cBAF-mediated nucleosomal remodeling in establishing robust GC
responses. These efforts will enhance our broader understanding of inflammation and immunity. In addition, our
work will add to an emerging paradigm describing a paradoxical role of unrestrained inflammation in limiting
GC responses, commonly seen in patients with severe pathogen infections and sepsis.

Public health relevance
Narrative Adaptive immune responses are important defense mechanisms against disease-causing pathogens. B lymphocytes are a crucial component of the immune system which are primarily responsible for generating antibodies to recognize and eliminate pathogens. Our proposal aims to elucidate the fundamental mechanisms by which B cells generate high-quality antibody responses, which are in turn critical for efficient immunity.